ACME POCT EMERGENCY COVID-19 VARIANT TESTING & INDEPENDENT TEST ASSESSMENT EVALUATION SUPPLEMENT

Project Summary/Abstract
Intentionally left Blank

Public health relevance
Project Narrative Intentionally left Blank